Regulation of Pulmonary Host Defenses by the Endoplasmic Reticulum Stress Sensor IRE1α

SUMMARY
Methicillin-resistant Staphylococcus aureus (MRSA) is the leading cause of hospital-acquired infection
worldwide, causing approximately 14 million infections annually in the United States alone. Increasing antibiotic
resistance observed with this pathogen highlights a compelling need to identify new therapeutic targets to treat
MRSA infections. Although directly targeting pathogens with antibiotics has been a successful approach for
treating infections, many pathogens, including MRSA, eventually become resistant to these drugs. As an
alternative, immunomodulatory strategies to enhance host defenses, such as those shown to be effective against
cancer cells, have the potential for treating drug-resistant pathogen infections. The Abuaita lab recently showed
that the endoplasmic reticulum (ER) stress sensor, IRE1α, is a key component in innate immune defense against
MRSA in macrophages, neutrophils, and in a murine skin abscess model of infection. This work found that IRE1α
controls macrophage and neutrophil antimicrobial functions by enhancing production of inflammatory molecules
including mitochondrial reactive oxygen species (MitoROS), neutrophil extracellular traps (NETs), and IL-1β, all
of which are essential for resolving MRSA infection in vivo. In the lung, ER stress occurs during infection, air
pollutant inhalation, and during the development of many pulmonary diseases such as Idiopathic Pulmonary
Fibrosis and Asthma. It is not well understood how IRE1α is involved in the progression and resolution of lung
diseases. As the lung is a vital organ, macrophages and neutrophils must adequately tune their responses to
ensure effective antimicrobial function without excessive tissue damage that could inhibit gas exchange.
Therefore, investigation of IRE1α-mediated stress responses during lung infection is expected to yield valuable
mechanistic insight into the regulation of pulmonary host defenses. The primary goal of this proposal is to
elucidate the role of IRE1α in pulmonary host defenses during MRSA infection. The central hypothesis is that
infection triggers IRE1α signaling, which enhances lung innate immune effector functions, includes bactericidal
activity and production of inflammatory mediators. The following Aims are designed to test this hypothesis: 1)
Characterize the requirement of IRE1α activation and MitoROS generation to lung macrophage inflammatory
responses and 2) Elucidate whether the IRE1α circuit aids or impedes innate immune defense against pulmonary
MRSA infection. Completing this study will define the ER stress response regulatory network in lung host defense
and will lay the groundwork for further studies to reveal cellular stress targets for potential antimicrobial
immunotherapies.